The Analysis of Signal Elements in Promoter Sequences.

The signal elements in promoter sequences are not well characterized. Initially, Dr. Mario-Ramrez collected a database of about 4700 sequences around the TSS of human genes, later increasing the size of the database by about a factor of 2. We then developed tests based on Poisson scan statistics to find nucleotide words (generally of length 8) that appear localized relative to TSSs (transcription start site). A-GLAM used these words as "seeds" for expansion to develop PSSMs (position-specific scoring matrices) characterizing systems of co-regulated genes. About 80 of these words occurred in two or three clusters. By validating our results with microarray data and gene ontology information, we were able to show that the same 8-letter word could have two different biological functions, depending on its position with respect to the TSS. Although this kind of positional dependency is a known phenomenon, our study showed that it is widespread in the human genome. In addition, with gold standard datasets and rigorous statistical tests, Drs. Spouge and Kim showed that Markov models and positional information improve transcription factor binding site (TFBS) prediction significantly (although not yet to practical accuracies). Moreover, they showed that the Markov models used in extant TFBS programs is inferior, both theoretically and practically, to the theoretically correct Markov model they proposed. Positional information and the theoretically sound Markov models have been incorporated into the publicly available motif-finding program A-GLAM. Tatiana Orlova (Volunteer Jun-Jul 2009) and Narayan Perumal (Visitor Jul 2009) collaborated in using AGLAM to investigate possible TFBSs for the TOL-like receptors important to the immune response. Dr. Spouge and Ms. Acevedo-Luna are presently developing a computer program to extend the statistical methods to the known TFBS motifs in the JASPAR database, to categorize the motifs according to positional preference, and possibly to use positional preference to discover combinations of the TFBSs in putative cis-regulatory modules.